Off the beaten path(way): Spatiotemporal investigation of protein assemblies controlling mitochondrial metabolism

Cellular metabolism is the crux of all organismal biology. Therefore, uncovering fundamental knowledge
regarding how metabolism is controlled will have far-reaching implications. Metabolic systems are traditionally
depicted as linear or circular pathways in textbooks. In reality, these processes are intricately governed by
complex, higher-order networks of macromolecules including proteins and lipids. A metabolon is a dynamic
cluster of proteins, cofactors, and small molecules that interact to control a metabolic process. Importantly,
metabolons are found across multiple biological systems from plants to humans, indicating their fundamental
importance in biology. Heme is an essential and conserved biomolecule that is produced by the community of
proteins forming the heme metabolon. Heme not only transports oxygen in red blood cells, but it also serves as
a catalytic cofactor for proteins governing multiple cellular signaling processes across all kingdoms of life. Thus,
determining how proteins assemble and disassemble to control heme metabolon formation will provide insight
into production of this critical molecule and also form the basis for studying other key metabolons. Specifically,
we will 1) isolate and solve the structure of the heme metabolon, 2) determine dynamics of metabolon formation,
and 3) investigate how defects in specific assembly steps alter metabolic output. We will accomplish this by
integrating high-resolution cryo-EM with time-resolved proteomics and metabolomics experiments to reveal
metabolon dynamics. The combination of these approaches will unite multiple hierarchies of cellular signaling,
transforming the static textbook snapshot of metabolism into a 3D movie of a living, breathing metabolic machine.
Addressing the fundamental and unknown question of how metabolic networks are controlled via coordinated
protein organization will have major impacts in broad areas of research, including cancer progression, diabetes,
and the immune response.

Public health relevance
Proteins do not exist in a vacuum; rather, proteins must function in a crowded cellular environment and need to precisely interact with other molecules to execute proper cell signaling. I will determine how communities of proteins assemble and disassemble to control cellular metabolism, in the process uncovering fundamental principles underlying formation of cellular machines necessary for life. In the long term, this investigation will lead to new insights of how damaged protein assembly may contribute to various metabolic disorders, with broad implications in diabetes, inflammation, and cancer research.